The Role of RHOA in Diffuse Gastric Cancer

PROJECT SUMMARY
This project focuses upon Diffuse Gastric Cancer (DGC), a frequently lethal cancer, marked
by its characteristic growth patterns with lack of cellular cohesion, highly invasive spread and
marked propensity for metastasis. This proposal builds upon new progress in the study of DGC,
bringing together a collaborative team of investigators with provocative new findings regarding the
role of RHOA in the pathogenesis of this disease and several newly developed mouse model
systems. These data and resources bring new opportunities to substantively advance the study of
these deadly and understudied cancers. A first set of data underlying this application followed our
recent identification of a novel stem cell population in gastric glands marked by Mist1 expression
(Yokoyama et al, Cancer Cell 2015). These cells were demonstrated to give rise to DGC following
engineered loss of tumor suppressor Cdh1. However, development of DGC required the secretion
of Wnt5a by cells in the stem cell niche, with Wnt5a acting by activating GTPase RhoA in the
Cdh1- null gastric cells. In parallel, we made a set of novel genomic discoveries, finding that ~20-
30% of DGCs harbor genomic aberrations impacting RHOA, either highly recurrent missense
mutations of RHOA or a recurrent fusion gene including ARHGAP26, a RHOA regulator (TCGA,
Nature, 2014). In this context, delineating the functions of RhoA in DGC pathogenesis, spanning
both the role of Wild-type RHOA following Cdh1 loss and the oncogenic functions of RHOA
mutations, emerge as critical paths towards the identification of therapeutic targets and
understanding of basic pathophysiology of DGC formation. In our first Aim, we evaluate activation
of wild-type RHOA in normal gastric corpus stem cells, and in early progression of Cdh1- deficient
diffuse gastric cancer. We propose to test our hypothesis that RHOA is a mediator of Wnt5a
effects upon corpus stem cells, especially following Cdh1 loss. These results will have immediate
relevance to the definition of mechanisms of DGC initiation, clearly informing efforts to prevent and
treat these deadly cancers. Our second aim evaluates RHOA somatic mutations in the initiation
and progression of diffuse gastric cancer. In this aim we further characterize the biochemical and
phenotypic effects of highly recurrent missense
mutations of the RHOA GTPase identified in DGC. We will also functionally validate which RHOA
effectors are essential for oncogenic activity of these mutants in both in vitro and in vivo systems,
including our novel DGC mouse model driven by Cdh1 loss and RhoA mutation. Through these
studies we hope to determine mechanisms of RHOA mediated transformation and identify specific
pathways that are critical to the pathogenesis of DGC, findings with immediate potential relevance
to the development of new therapeutic targets.

Public health relevance
PROJECT NARRATIVE: Diffuse Gastric Cancer (DGC) is a highly lethal cancer lacking effective therapies. This project follows findings of recurrent mutations in GTPase protein RHOA in human DGC and that RHOA activation is critical for the development of DGC in murine models. In this proposal, we will validate our hypothesis regarding the role of RHOA in DGC development and evaluate mechanisms of action of novel RHOA mutations, building towards development of new means to prevent and treat these cancers.